Project Narrative - OADDL Testing Support for CVM Vet-LIRN

Abstract - OADDL Testing Support for CVM Vet-LIRN (PI-Akhilesh Ramachandran)
The aim of this proposal is to seek funding for Oklahoma Animal Disease Diagnostic Laboratory (OADDL
to support critical CVM Vet-LIRN (Veterinary Laboratory Investigation and Response Network)
surveillance and diagnostic programs. Services within capabilities of OADDL will be offered to test
clinical samples, animal food/feed/drug samples, environmental samples related to animal
food/feed/drug. In addition we will also offer animal diagnostic necropsy services as needed. OADDL is a
full service diagnostic laboratory founded in 1976 and has maintained continuous accreditation with the
American Association of Veterinary Laboratory Diagnosticians (AAVLD) since 1978. OADDL has the
necessary expertise, infrastructure and cutting edge technology to provide tremendous benefit to CVM
Vet-LIRN critical projects.

Public health relevance
Project Narrative - OADDL Testing Support for CVM Vet-LIRN Oklahoma Animal Disease Diagnostic Laboratory (OADDL) will offer its expertise and services to participate in critical disease testing and surveillance projects initiated by the Food and Drug Administration (FDA), Center for Veterinary Medicine (CVM) Office of Research Veterinary Laboratory Investigation and Response Network (Vet-LIRN). OADDL will provide testing support and expertise in foodborne and other disease investigations, disease surveillance studies, pathogen characterization, and test methods development. These efforts will help strengthen Vet-LIRN’s response capabilities especially in the event of disease outbreaks and implement appropriate control measures to protect public and animal health.